Analgesic potential of novel peripherally-restricted CB1 ligands

Project Summary
Preclinical studies that have shown significant analgesic efficacy of targeting peripheral cannabinoid type
1 receptors (CB1Rs) in diverse pain models contrast with disappointing results from clinical studies where the
analgesic efficacy of targeting CB1Rs, including using peripherally selective compounds, has been inconsistent.
This discrepancy likely results from a number of addressable issues that we will resolve in this proposal.
Perhaps cannabinoid therapeutics tested in humans to date do not sufficiently activate CB1R in the
periphery. Inadequate peripheral restriction has hampered prior clinical trials of purported “peripherally restricted”
cannabinoids. Partitioning of these compounds into the brain leads to dose limiting psychoactivity. We recently
developed VIP36, a novel CB1R agonist that shows robust analgesic actions and dramatically improved
peripheral restriction. The improved peripheral selectivity of VIP36 will allow maximal activation of peripheral
CB1R without psychoactivity associated with CB1R activation in the brain.
Perhaps the way we have done preclinical testing in animals is not predictive of efficacy in humans. In
Aim 1 of this application, we test the efficacy of VIP36 in mouse models of post-traumatic headache, post-
operative pain, and a new model of nerve injury-induced pain. These models have improved face validity for
human clinical pain. We also use behavioral endpoints that assess affective-motivational aspects of pain, which
will enhance preclinical validation and provide greater predictive power for utility in humans.
Perhaps there are differences in CB1R expression or function between rodents and humans. In Aim 2,
we will test whether CB1R is expressed in similar cell populations in dorsal root ganglia (DRG) and trigeminal
ganglia in mice and humans. We will also test whether CB1R activation has similar functional effects in mouse
and human DRG neurons using electrophysiology.
Perhaps prior cannabis exposure blunts analgesic efficacy of CB1R ligands in humans. Frequent
cannabis use leads to downregulation of CB1R in human brain. This could lead to reduced efficacy of cannabinoid
analgesics. Given the widespread recreational and medical use of cannabis, it is conceivable that CB1R
downregulation or tolerance in participants of clinical trials could confound results. In Aim 3, we test whether a
history of frequent THC exposure leads to cross-tolerance to analgesic effects of THC and VIP36. We also ask
whether frequent THC exposure leads to reduced CB1R expression in dorsal root ganglia (DRG) and trigeminal
ganglia in mouse models and in DRG recovered from human organ donors with a history of daily cannabis use.
Collectively, our approach is designed to evaluate the potential analgesic efficacy of peripherally
restricted CB1R agonists and obtain data that will either support or refute the notion that this is likely to translate
effectively to humans. The proposed studies will also significantly advance our understanding of human
cannabinoid receptor biology.

Public health relevance
Project Narrative This project will test whether drugs that activate a cannabinoid receptor outside the brain can produce pain relief in animal models of human pain conditions. We will also test whether human sensory neurons express these cannabinoid receptors in similar cell types seen in mice that are used for early drug development studies. This information will help us understand whether drugs that target these receptors outside the brain might be effective in treating human pain.